Removal of Palladium from Pharmaceutical Process Chemistry Reactions

Project Summary/Abstract (30 Lines)
Palladias will develop inexpensive and reusable sorbents that cost effectively remove
palladium from the products of palladium-catalyzed cross-coupling reactions.
Palladium-catalyzed cross-coupling reactions are among the most widely used reactions in
pharmaceutical discovery. NIGMS has invested approximately $107 million in researching and
developing palladium-catalyzed cross-coupling reactions. This project addresses the NIGMS
topic: “Synthetic chemistry to efficiently produce methods for molecules of biomedical
significance.”
Despite their versatility and power, these reactions are not widely used in pharmaceutical
process chemistry to synthesize medicines on a production scale because of the difficulty of
removing the palladium catalysts from the products of these reactions. Palladias proposes to
use high throughput screening to generate chelating sorbents to remove residual palladium from
a set of three common palladium-catalyzed reactions.
Palladias has developed high-throughput screening technology to identify highly selective
sorbents that selectively extract metals from complex matrices. This screening technology
identifies selective sorbents from combinatorial libraries. Palladias will screen for palladium
scavengers, and characterize the sorbents identified in this project for reusability, kinetics, and
binding affinity.

Public health relevance
Project Narrative (Three Sentences) Palladium-catalyzed reactions are some of the most widely used reactions in the pharmaceutical industry and allow the formation of otherwise difficult to synthesize carbon- carbon or carbon-heteroatom bonds. Palladium is much less widely used in process chemistry to synthesize drugs and drug candidates on a larger scale, because palladium can be difficult to remove to allowable thresholds. Palladias will develop scavengers to remove palladium from the reaction products, so that these reactions can be used in process chemistry.